Data Science Core

OK-INBRE Data Science Core Summary
The Data Science Core (DSC) builds on the success of the existing OK-INBRE Bioinformatics Core and expands
the Core to include additional data science expertise through the Oklahoma Medical Research Foundation
(OMRF) to meet the objectives of this initiative. The Core will provide both traditional biostatistics methods and
computational and bioinformatics approaches, particularly in the area of genomics, as well as microbial
genomics, microbiomics and transcriptomics. Together, the OUHSC and OMRF combined DSC will oversee the
educational advancement and vast breadth of collaborative projects and will provide data science and
bioinformatics education, workforce development, and outreach, including initiatives to promote data deposition,
cataloging and utilization and provide data analysis services to all the OK-INBRE network partners across a wide
array of disciplines. The DSC will address the goals of the INBRE program by maintaining bioinformatics support
throughout the OK-INBRE network and expanding training opportunities to data scientists and information
specialists to build the research capacity necessary for Oklahoma to operate within today’s highly integrated
biomedical research landscape.